CGMP RE-SUPPLY OF HPV 16L1/16RG1

The purpose of this task order is to re-supply recombinant human papillomavirus type 16 chimeric L1/L2 virus-like particles (VLPs) for use as a vaccine (HPV16L1/16RG1 VLP vaccine) in ongoing human clinical trials, through the tasks identified in the Statement of Work, dated 12/18/2020.